Adaptation and Implementation of SBIRT for Adolescents with Chronic Medical Conditions Hospitalized in Pediatric Inpatient Units

Title: Adaptation and Implementation of SBIRT for Adolescents with Chronic Medical Conditions Hospitalized
in Pediatric Inpatient Units
Project Summary/Abstract:
Adolescents with a chronic medical condition (A-CMC) are more likely to misuse and initiate alcohol and other
drugs (AOD) at younger ages compared to adolescents without CMCs. A-CMCs account for the majority of
pediatric inpatient hospitalizations as A-CMCs are often admitted for an acute inpatient stay following an
emergency department visit for an exacerbation of their disease. However, A-CMCs are not routinely screened
for alcohol use in pediatric inpatient settings. Thus, the pediatric inpatient setting provides clinicians a critical,
but missed, opportunity to universally screen for alcohol use among A-CMCs once medical concerns are
stabilized. The current study addresses this gap in the care cascade by examining the workflow processes in
an urban pediatric hospital’s inpatient units, adapting Screening, Brief Intervention, and Referral to Treatment
(SBIRT) to the population and setting, and identifying SBIRT implementation strategies to pilot in a single arm
hybrid type III effectiveness-implementation trial. This research is attained via three Specific Aims. In Aim 1, the
candidate will observe inpatient workflows and collaborate with a Partner Steering Committee (PSC)
composed of hospital staff (e.g., clinicians, administrators, information technology), A-CMCs, and parents to
adapt SBIRT delivery and intervention components for the inpatient setting and population. Aim 2 will involve
continued partnership with the PSC, to select, specify, and prioritize a set of SBIRT implementation strategies
ideally suited for the inpatient setting and population. Aim 3 will consist of a single arm pilot hybrid type III
effectiveness-implementation trial that simultaneously tests the set of implementation strategies selected in
Aim 2 (primary outcome) and the SBIRT intervention adapted in Aim 1 (secondary outcome). To conduct this
research, the candidate, Dr. Summersett Williams, requires training in three key areas: 1) expert knowledge
and application of intermediate and advanced IS methods, including implementation strategy selection and
evaluation of implementation outcomes; 2) application of human- and equity-centered design methods,
including intervention adaptation and usability testing; and 3) expert application of the learning health system
model to improve the health of A-CMCs who engage in risky drinking through enhanced healthcare system
performance. These training aims will be supported by Ann & Robert H. Lurie Children’s Hospital of Chicago
and by the candidate’s mentorship team. The mentorship team will be led by Primary Mentor Dr. Sara Becker,
an expert in
implementing SBIRT targeting risky drinking in pediatric health settings. The proposal will also be
supported by Drs. Robert Garofalo, Lisa Kuhns, and Patricia Franklin, experts in intervention adaptation,
human- and equity-centered design methods, and the learning health system model, respectively. Taken
together, this research and career development plan will advance a significant public health issue by advancing
access to evidence-based alcohol health services for a vulnerable pediatric population while launching Dr.
Summersett William’s career as an independent implementation scientist.

Public health relevance
Public Health Relevance Statement Project Narrative: Adolescents with a chronic medical condition (A-CMC) have high rates of risky drinking and drug use and account for the majority of pediatric inpatient hospitalizations. However, A-CMCs are not routinely screened for alcohol use in pediatric inpatient settings, highlighting a major missed opportunity. This mentored research proposal will facilitate the implementation of SBIRT in inpatient units within a large urban pediatric hospital, while providing preliminary data to inform the development of a highly scalable approach that can be used in pediatric hospitals across the country.